A novel multi-omics approach to explore mechanisms of lean mass recovery

MIRA Abstract
This proposed research explores the complex phenomenon of cachexia, a condition
characterized by severe weight loss and muscle wasting that occurs in various terminal
illnesses such as sepsis, cancer, and heart failure. Despite advancements in addressing
underlying chronic illness, there remains a critical need to determine the mechanisms that can
reverse lean mass losses during cachexia, which will inform the development of effective
therapeutics for recovery. During endurance flight and fasting, migratory birds naturally
experience dramatic reductions in lean body mass, in excess of what is experienced during
cachexia, yet these animals rapidly recover muscle and organ mass losses quickly, with few
functional consequences. This proposed research investigates the functional consequences of
tissue loss in multiple organ systems, the metabolomic profile of catabolic and anabolic states,
and the mechanisms of tissue regeneration in migratory birds with the goal of using this novel,
natural model to discover new mechanisms associated with tissue anabolism. We propose to
use innovative whole animal approaches to investigate lean body mass reductions, enabling
longitudinal studies of organ system function, molecular mechanisms, and recovery processes
using this novel, avian natural system. Over the next five years, our goals include combining
functional assessments with metabolomics and transcriptomics to uncover unique mechanistic
determinants of recovery. Key questions to be addressed involve understanding structural-
functional relationships, analyzing metabolite and cytokine responses during lean mass loss,
and elucidating molecular pathways driving tissue degradation and remodeling. By leveraging
expertise in organismal physiology, metabolism, and molecular biology, we aim to contribute
significantly to the field's knowledge base. Ultimately, our research strives to inform the
development of novel models and therapeutic strategies for combating cachexia and promoting
recovery in patients with debilitating conditions.

Public health relevance
MIRA Narrative There is currently an unmet medical need to understand the biological mechanisms that may slow the progress of, or aid in the recovery from, cachexia, which is a terminal phase of several diseases including sepsis, numerous cancers, AIDS, and others. The work proposed here provides a novel approach to make progress toward meeting this need, as it seeks to expand our knowledge of the functional consequences of lean mass loss, as well as the mechanisms of recovery in a non-pathological, novel model system.